Developing Novel Ambroxol Analogs as Disease-Modifying Therapies for Alzheimer's Disease and Related Dementias

Project Summary/Abstract
Alzheimer’s disease (AD) is a devastating neurodegenerative disorder that affects millions of older adults
worldwide, leading to cognitive decline, loss of independence, and signiﬁcant healthcare burdens. Despite the
emergence of monoclonal antibodies (mAbs) targeting beta amyloid, these therapies are costly, carry notable
safety risks, and offer only partial clinical beneﬁts. An urgently needed complementary approach is to stimulate
the cell’s own clearance machinery for pathogenic proteins—particularly amyloid beta (Aβ) and tau—which
accumulate and disrupt neuronal function.
This project will advance pharmacokinetically stabilized analogs of the ambroxol – a small molecule drug with a
long safety record in humans, excellent brain penetrance, and potent effect on the lysosomal waste clearance
system – towards development as small molecule Alzheimer’s disease therapeutic. Our preliminary evidence
shows that ambroxol can reverse AD pathology, but low stability affects its clinical performance. As a result we
have now engineered two ambroxol analogs (ZW-002, ZW-010) with markedly improved metabolic stability. These
compounds retain ambroxol’s lysosomal-enhancing capacity yet exhibit extended half-lives, potentially allowing
safer, more efficacious dosing.
This Phase I SBIR proposal seeks to:
1. Scale up manufacturing of ZW-002 and ZW-010 under non-GLP conditions (Aim 1), optimizing synthetic
methods and partially validating analytical assays.
2. Conduct short-term toxicology in healthy adult mice (Aim 2) to identify any unanticipated toxicities and
establish safe dosing parameters.
3. Evaluate efficacy in the 3xTg AD model under both prevention and treatment paradigms (Aim 3) to conﬁrm
whether these analogs can reduce or even reverse Aβ and tau accumulation.
By the end of Phase I, we will determine which analog best balances manufacturability, safety, and disease-
modifying capability, paving the way for IND-enabling studies and clinical translation. Ultimately, our approach
aims to deliver a safe, orally available, and cost-effective therapy that harnesses the intrinsic power of lysosomal
clearance to combat Alzheimer’s disease—potentially transforming how we treat neurodegenerative disorders
characterized by toxic protein aggregates.

Public health relevance
Project Narrative Alzheimer’s disease (AD) exacts an enormous toll on patients, caregivers, and healthcare systems, yet current treatments remain limited, costly, and only partially effective. This project seeks to develop safer, more potent small-molecule analogs of ambroxol – an orally available, lysosome-activating compound with an established safety record – that can more robustly clear pathological beta amyloid and tau. By enhancing the brain’s intrinsic protein-degradation pathways, these novel agents have the potential to become cost-effective, disease-modifying therapies for AD, ultimately reducing the burden of neurodegenerative disorders and improving the quality of life for millions of individuals and their families.